Translational Global Infectious Disease Reseach Center

PROJECT SUMMARY: Overall
As demonstrated by the COVID-19 pandemic, infectious diseases are dynamic, constantly evolving threats that
cause significant morbidity and mortality in all populations worldwide. The University of Vermont’s Translational
Global Infectious Diseases Research (TGIR) Center of Biomedical Research Excellence (COBRE) began in
2018 under a Phase 1 award with aims to support and develop the research careers of the next generation of
scientists and to build institutional strength in global infectious disease research. The TGIR COBRE’s
overarching scientific goal is to perform impactful research to prevent and control infectious diseases of global
significance, particularly in low-resource regions of the world. A unique feature of the TGIR COBRE is its
commitment to bridging the culture gap between biomedical and quantitative data scientists. Phase 1 funding
successfully supported seven research project leaders (RPLs), recruited four new junior faculty, and began a
pilot award program that funded nine additional research projects. The Administrative Core offered
comprehensive scientific, administrative, and career-development support, and new educational and academic
programs, including Mentoring and Visiting Scholar Programs. The two research cores - the Human and
Population Research (HPR) Core and the Mathematical and Computational Predictive Modeling (MCP) Core –
provided prioritized services directly to RPLs, pilot project awardees, and junior faculty recruits in addition to
educational and training opportunities.
Phase 2 of the TGIR COBRE will build and consolidate this institutional growth and critical mass of faculty,
including retention opportunities for ‘graduated’ RPLs. With a primary focus on developing junior faculty, and
with the help of senior mentors and an improved mentoring plan, the TGIR COBRE will initially support the
careers and research of four RPLs as well as new pilot award faculty. Three externally recruited faculty will
complement existing areas of research strength. In addition, the TGIR COBRE will focus on RPL pipeline
faculty and on broadening collaborations across campus and with other IDeA state programs. With institutional
support, new initiatives in Phase 2 will position the TGIR COBRE for long term success. These initiatives
include plans for multi-disciplinary grant proposals and provision of formal grant writer support. Financial and
logistic support will also be provided for national scientific meetings to be held at UVM in order to broaden
networking, visibility, and collaborative opportunities. A bioinformatician has been added to the MCP Core,
expanded data management and biorepository services have been added to the HPR Core, and the
Administrative Core now has enhanced focus on career development for physician-scientists. Evaluation of
TGIR COBRE progress will be a continuous process led by the Leadership Team with the support of a
dedicated Advisory Committee. We anticipate the TGIR COBRE becoming a sustainable academic research
hub in global infectious diseases.

Public health relevance
NARRATIVE: Overall As demonstrated by the COVID-19 pandemic, infectious diseases are continuously evolving threats that cause substantial morbidity and mortality in all populations. Toward the prevention and control of globally important infectious diseases, we propose continuation of the Translational Global Infectious Diseases Research (TGIR) Center. The TGIR Center supports the research and career development of the next generation of scientists in biomedical and quantitative/computational scientific fields and builds a strong collaborative research team to diminish the global health burden from infectious diseases.